Mapping Genetic Pathways Associated With Neurodevelopmental Variability after Fetal Anti-Seizure Medication Exposure

PROJECT SUMMARY
The mechanisms underlying the variability of cognitive outcomes seen in children born to women with epilepsy
(WWE) remain poorly understood, and our ability to predict individual outcomes is limited. As discontinuation of
anti-seizure medications (ASMs) during pregnancy is often not an option, current practice focuses on optimizing
medical management prior to and during pregnancy for WWE, knowing that a variable degree of teratogenicity
could be seen in patients treated with ASMs. However, we cannot effectively counsel WWE on how to mitigate
the risk to their children beyond avoiding specific ASMs or polypharmacy. Genetic factors account for up to 50%
of cognitive variation, but the susceptible genotypes that interact with ASM exposure in WWE and their children
remain unknown. Hence, there is a compelling need for properly controlled studies in WWE during pregnancy to
investigate factors affecting children's long-term outcomes. This proposal aims to investigate the impact of
genetic variants and pathways in WWE and their children on the children's long-term cognitive status
after fetal ASM exposure. My pilot study showed that genetic variants in WWE that are known to affect ASM
transport and metabolism were associated with their children's cognitive outcome at 3 years of age, indicating
the genetic background of WWE could potentially impact the children's cognitive outcome following ASM
exposure. My hypothesis is that genetic variants in either or both WWE and their children are associated with
the variance of cognitive outcomes seen in children after fetal ASM exposure. Further, combining clinical/external
factors and genetic/intrinsic biomarkers of WWE and their children will create a better predictive model of
neurocognitive outcomes in children of WWE. These findings could pave the way for the development of
preventive strategies to optimize care for WWE and advance our understanding of the underlying mechanisms
driving heterogeneity in children's neurodevelopmental outcomes despite similar ASM exposures.
Aim 1: Determine the correlation between genetic variants and pathways related to ASM transport and
metabolism in WWE and their children, and the children’s neurodevelopmental outcomes following fetal ASM
exposure, using a targeted approach.
Aim 2: Identify novel candidate genetic variants and pathways in WWE and their children associated with
neurodevelopmental outcomes following fetal ASM exposure, using a machine learning approach.
To achieve my objectives, I will have direct guidance from an internationally renowned team with expertise in
cognitive neurology, epilepsy, genetics and bioinformatics. This mentorship will help me develop my own
expertise in interfacing with these areas. The generated data will bridge existing gaps in our management of
WWE to optimize their children's outcomes and lay the groundwork for future diagnostic approaches utilizing
innovative precision medicine methods.

Public health relevance
PROJECT NARRATIVE Over one million women with epilepsy (WWE) of childbearing age in the USA are considered at higher risk for adverse pregnancy outcomes, but our ability to predict individual outcomes is limited due to a lack of understanding of how genetic factors interact with antiseizure medications. This proposal aims to investigate the impact of genetic factors in WWE and their children on the children’s long-term cognitive status. The findings from this study will advance our knowledge of the mechanisms that impact long-term neurodevelopmental outcomes in children of WWE, and pave the way for future innovative, personalized therapeutic and preventative approaches to improve care for WWE.